BIOSTATISTICS/EPIDEMOLOGY CORE

PROJECT SUMMARY (See instructions): The Biostatistics/Epidemiology Core will be responsible for all statistical, data management, and epidemiological aspects of the Mayo Clinic Urology O'Brien Center research grant. It is expected to serve all major projects as well as pilot projects and will be staffed by members of the Divisions of Biomedical Statistics and Informatics and Epidemiology who have expertise in statistical analysis, data management, and study design. Further, the Core investigators have extensive experience in the applications of quantitative methods to urologic and kidney problems, including nephrolithiasis. The objectives of the Core are to 1) provide high quality consultation to project investigators regarding study design, data analysis and interpretation of results, 2) maintain and extend the existing Olmsted County kidney stone database, 3) develop additional high quality linkable databases and quality control procedures for O'Brien Center research grant studies , and 4) foster and develop junior faculty in the statistical and epidemiological approach to clinical questions in nephrolithiasis.

Public health relevance
RELEVANCE (See instructions): The existence of the Biostatistics/Epidemiology Core will provide the O'Brien Center research grants with uniform and efficient plans for protocol design, data management, quality control, and statistical analysis. Further, Core investigators will have a broad view of the O'Brien Center research grant, which will allow them to identify potential new interdisciplinary hypotheses and projects.